H3Africa Administrative Coordinating Centre: Enabling and Supporting Genomics and Health Research Capacity Building in Africa

Abstract
The Human Heredity and Health in Africa (H3Africa) Consortium aims to influence continent-
wide research capacity in health and genomics through support from the National Institutes
of Health and the Wellcome Trust. H3Africa has approximately 500 members from 26
different projects, networks and sub-nodes spanning 32 countries. This consortium is
supported by over 10 working groups, an Informatics Network, three Biorepositories, and a
Data and Biospecimen Access Committee. H3Africa is governed by a Steering Committee
with oversight from an Independent Expert Committee. Such complex pan-African networks
of inter-institutional, multi-national research partnerships require an Administrative
Coordinating Centre for cohesion and coordination. The H3Africa Administrative
Coordinating Centre (H3ACC) builds on previous strengths and accomplishments to
enhance provision of support to the H3Africa research and training grants through six aims
outlined below: 1) provision of quality and reliable administration and line of communication
2) provision of fiscal and logistical support for the consortium meetings and cross-
Consortium activities 3) being custodians and overseers of cross-Consortium collaborations,
resources and databases 4) facilitating the pooling of training resources, opportunities and
career-tracking of Fellows 5) monitor, evaluate and report on the progress and impact of the
H3ACC and the consortium 6) facilitation of stakeholder engagement activities and
awareness of genomics research targeted at increased buy-in. The H3ACC activities will
result in a networked, efficient and sustainable H3Africa.

Public health relevance
Project Narrative The Human Heredity and Health in Africa (H3Africa) Consortium will benefit from administrative and operational support provided by the H3Africa Administrative Coordinating Centre (H3ACC). Through provision of its support services, the H3ACC will build institutional and continental capacity and knowledge in management of pan-African consortia. The H3ACC will also promote sustainability and awareness in Genomics and Health in Africa through increased promotion of H3Africa amongst the public, policy makers, funders and other key stakeholders.